Repositioning Immunotherapy in Veterans with Lung Cancer

PROJECT SUMMARY
Lung cancer is the deadliest cancer in American war Veterans. Due to limited uptake in lung cancer screening,
one third of patients present locally advanced (Stage III) non-small cell lung cancer (NSCLC) at diagnosis, and
the overwhelming majority have unresectable disease. The addition of adjuvant immune checkpoint blockade
(ICB) to concurrent chemoradiotherapy (CRT) has resulted in significant improvements in overall survival at five
years for unresectable Stage III NSCLC. Unfortunately, up to a quarter of Veterans with Stage III lung cancer
are unable to tolerate this trimodality therapy. An equal proportion of Veterans discontinue therapy secondary to
treatment progression, highlighting the need for both more effective and better tolerated treatment strategies. In
resectable NSCLC, neoadjuvant immunotherapy can induce major pathologic responses (MPR) in up to half of
patients. Neoadjuvant therapy is better tolerated in many solid malignancies including locally advanced rectal
cancer. Moreover, neoadjuvant immunotherapy more than halves the recurrence rate as compared to adjuvant
immunotherapy in locally advanced melanoma. We hypothesize that 1.) neoadjuvant chemoimmunotherapy will
improve the progression-free survival of patients with unresectable Stage III NSCLC, 2.) PET-adaptive
radiotherapy after neoadjuvant chemoimmunotherapy will reduce radiation field sizes and will enhance the
treatment tolerance and outcomes in Veterans with unresectable NSCLC. We will test this hypothesis in two
aims: Specific Aim 1: Conduct a multi-site single arm open label Phase II clinical trial to assess if neoadjuvant
chemoimmunotherapy followed by adaptive radiotherapy is effective in Veterans with unresectable Stage III
NSCLC. Up to thirty Veterans with unresectable Stage III NSCLC with ≥ 1% PD-L1 expression will be enrolled
across seven VAs. Three cycles of neoadjuvant chemoimmunotherapy will be given followed by PET-adaptive
radiotherapy and adjuvant nivolumab. The primary endpoint of the trial will be the median progression-free
survival. Secondary endpoints will include treatment tolerance, completion of planned courses of therapy, best
overall response rate, and overall survival. Matched controls will be drawn from a contemporaneous cohort of
Veterans with unresectable Stage III NSCLC enrolled on an observational prospective study. We anticipate that
completion of this work will identify that neoadjuvant chemoimmunotherapy will improve patient outcomes and
treatment tolerance. Specific Aim 2: Examine whether baseline and on-treatment factors are indicative of anti-
tumor immunity and clinical benefit from chemoimmunotherapy in Veterans with unresectable Stage III NSCLC.
Preliminary data suggests that tissue immunophenotype may be predictive of benefit from ICI in the metastatic
setting. We will perform correlative exploratory analyses of tissue samples of patients enrolled in this trial to
extend these findings to Stage III NSCLC. In Aim 2A, we will perform next generation sequencing and evaluate
whether the recently validated Immune Response Score is prognostic and predictive in locally advanced NSCLC.
We will evaluate whether circulating tumor DNA (ctDNA) or radiographic responses correlate with outcomes.
Univariate and multivariate modeling will be used to improve precision oncology approaches. Completion of
these studies will identify additional tumoral biomarkers potentially predictive of the efficacy of
chemoimmunotherapy in Stage III NSCLC, guiding future clinical trials.

Public health relevance
Lung cancer kills more Veterans than any other cancer. Veterans are more likely than civilians to present with lung cancer that is unresectable and spread to the lymph nodes (Stage III). Immune checkpoint blockade can cure a subset of Veterans with locally advanced Stage III or metastatic Stage IV cancer. At present, the standard of care for Stage III NSCLC is six weeks of chemotherapy and radiation followed by one year of maintenance immune checkpoint blockade. This is challenging for many patients and may not be needed in all cases. We have found Veterans whose lung cancer expresses immune checkpoints most benefit from immune checkpoint blockade. In this clinical trial, we are trying to see if by using the immunotherapy upfront, overall tolerability of the three treatments can be improved. If this is true, we may be able to help more Veterans with lung cancer live longer lives with less treatment toxicity.